Continuation of the Symptoms of Lower Urinary Tract Dysfunction Research Network (LURN) Data Coordinating Center

Contact PD/PI: Merion, Robert M
Project Summary
In the Continuation of the Symptoms of Lower Urinary Tract Dysfunction Research Network (LURN II), the
investigators will advance the subtyping of study participants with Lower Urinary Tract Symptoms (LUTS) with
the expectation that clinically useful patient subtypes will be identified. Research efforts will include continued
analysis of data and biospecimens from LURN I and development of additional, new and novel collaborative
studies to further improve our understanding of lower urinary tract dysfunction, both designed to generate
findings that may inform future clinical studies (e.g., clinical treatment trials) and ultimately improve clinical
management and patient outcomes.
Studies will also refine and evaluate the longitudinal performance of clusters identified in LURN I for patient
subtyping, including response to treatment. We will incorporate insights from the LURN I organ-based
diagnostics pilot study and biomarker pilot studies. We will evaluate the LURN Comprehensive Assessment of
Self-reported Urinary Symptoms (CASUS) instrument in populations with lesser severity of LUTS than seen in
the tertiary care setting in LURN I.
Consistent with the description in the RFA for this second funding cycle of LURN, the primary goal of this
proposal is to better define clinical phenotypes of patients with LUTS, to better describe the impact and
diversity of symptoms, and to develop new patient-centric tools for improved measurement of clinical
symptoms, all with the goals of informing future clinical studies and improving patient care and outcomes. It is
anticipated that the network will consist of up to six clinical sites and a single data coordinating center (DCC).
The DCC for the LURN study is charged with providing coordination, communications and logistical support,
clinical study design, centralized data management, biosample management, quality assurance, and analytical
support to the research sites and the NIDDK Project Scientist for all LURN studies. The proposing team is
submitting this response to RFA-DK-18-511 to continue as the DCC for the network.
Page 6
Project Summary/Abstract

Public health relevance
Contact PD/PI: Merion, Robert M Project Narrative The Symptoms of Lower Urinary Tract Dysfunction Research Network (LURN) II will study people who have symptoms of lower urinary tract dysfunction (LUTD). The scientific collaborators will use data collected during the studies to refine symptom-based patient clusters that will help doctors better diagnose and treat the symptoms of LUTD and try to determine whether there are biomarkers that can help improve our understanding of these symptoms and the diseases that cause them. The scientists will ask patients to participate in studies that will include the development of surveys to help assess treatment outcomes in future trials of new treatments for LUTD. Page 7 Project Narrative